Precise GI Drug Delivery and Modeling with Pharmacomicrobiomics

Precise GI Drug Delivery and Modeling with Pharmacomicrobiomics
Project Summary/Abstract
The gut microbiome plays a critical role in modulating drug metabolism, efficacy, and safety, influencing how
therapeutic compounds are absorbed, distributed, and processed in the body. This is particularly important in
prodrug design, which seeks to achieve specific gastrointestinal (GI) targeting, sustained release, and reduced
side effects, for GI-related disease and chronic treatments. Variations in microbiome composition can lead to
significant differences in drug responses among individuals. Conversely, many oral drugs can also alter the
microbiome, inducing imbalances (or dysbiosis) that negatively affect gut health and immune function.
Understanding the bidirectional interactions between drugs and the microbiome is essential for advancing
precision medicine, particularly in gut-targeted therapies. However, there remains a significant gap and a lack of
tools to understand how the microbiome affects drug pharmacokinetics (PK) and efficacy, as well as how
therapeutics impact microbiome composition and the production of metabolites that maintain host immune
homeostasis. This research program focuses on developing a novel nano-prodrug delivery platform that targets
microbiome-modulating molecules to the distal GI tract, where most of commensal bateria resides, and
integrates physiologically-based pharmacokinetic (PBPK) modeling with pharmacomicrobiomics. The project
aims to reveal the bidirectional interactions between microbiome composition and prodrug metabolism, exploring
how variations in the gut microbiome influence drug release and response, and conversely, how drugs alter
microbiome composition and function. We will use short-chain fatty acids (SCFAs) and tryptophan metabolites—
key microbial metabolites known to regulate immune, metabolic, and microbiome health—as model drugs to
achieve two primary goals: 1) designing a nano-prodrug platform capable of delivering therapeutics and
modulating microbiome functions in the distal gut, coupled with a PBPK model for precise GI drug delivery; and
2) coupling PBPK modeling with pharmacomicrobiomics to study the interactions between microbial metabolites
and the microbiome using nano-prodrugs. By integrating drug delivery systems with PBPK models and
pharmacomicrobiomics, this research will advance our understanding of the temporal and spatial release kinetics
from various oral drug formulations and their downstream effects on both the host and the microbiome. These
insights will contribute to a broader understanding of clinical pharmacology and drug metabolism across multiple
systems, paving the way for future therapeutic strategies that target both microbiome health and disease
intervention.

Public health relevance
PROJECT NARRATIVE Prodrugs and nanoformulations are emerging as promising strategies for targeted or sustained drug release in GI-related diseases and chronic treatments. This project will develop a versatile nano-prodrug delivery platform targeting specific GI segments, applying physiologically-based pharmacokinetic (PBPK) modeling with pharmacomicrobiomics to systemically model in vivo behavior and understand the interactions between drug release and the microbiome. The results of this study will benefit future oral drug development, particularly for formulations requiring customized release profiles and microbiome-modulation properties.